Efficacy of an mHealth + e-Navigator stepped care intervention for ART adherence among Latino MSM

PROJECT SUMMARY
Approximately 40% of Latino MSM with HIV do not achieve viral suppression—an estimate that has likely
worsened due to COVID-19 Pandemic stressors such as unemployment, loss of health insurance,
homelessness, and exacerbated mental health and substance use disorders caused by the COVID-19
pandemic. Antiretroviral therapy (ART) adherence is associated with decreased viral load, increased CD4
counts, fewer hospital days, slower disease progression, and longer survival. Adherence also helps prevent
drug resistance and reduces HIV transmission risk. The primary objective of this study is to evaluate the
efficacy of stepped care strategies to improve ART adherence among adult Latino MSM with HIV using a
sequential, multiple assignment, randomized trial (SMART). The trial will compare a stepped care strategy of
delivering TXTXT first and stepping up to remote patient navigation for non-responders vs. a stepped care
strategy of delivering TXTXT + e-Navigation first and stepping up to EMA-supported e-Navigation for non-
responders. Both, TXTXT (“Treatment Text”) and the foundations of the e-Navigation interventions are CDC
evidence-based interventions (EBI). We propose to use a SMART design which explicitly allows building,
testing, and optimizing stepped care strategies without compromising rigor or randomization. We propose three
specific aims: Aim 1. Compare the immediate (6-month) and sustained (9- and 12-month) efficacy of two static
(non-stepped) treatment regimens (TXTXT alone vs. TXTXT + e-Navigation) on ART adherence and viral
suppression among Latino MSM with HIV. Aim 2. Compare the immediate (6-month) and sustained (9- and
12-month) efficacy of two stepped care strategies (TXTXT with added e-Navigation for non-responders vs.
TXTXT + e-Navigation with added EMA support for non-responders) on ART adherence and viral suppression
among Latino MSM with HIV. Aim 3. Identify baseline and time-varying moderators on the association
between stepped care strategy and ART adherence and viral suppression among Latino MSM with HIV. The
proposed study is innovative by culturally adapting and combining two EBIs, using a stepped care approach,
remote patient navigators, adaptive EMA components, and a SMART design. The proposed study is significant
because it provides data on the efficacy of two scalable EBIs in one efficient design and provides data on
enhanced treatment options for non-responders. The study is also significant because it targets an NIH health
disparity population (Latino MSM) and addresses multiple domains and levels of influence on health and health
disparities. It also targets people living in an Ending the HIV Epidemic geographic focus area with the highest
HIV diagnosis rate in the nation (South Florida), thereby supporting the objectives of reducing HIV disparities in
populations at high risk and living in the Southern US.

Public health relevance
PROJECT NARRATIVE The successes of antiretroviral therapy in improving and extending life for people with HIV are significantly diminished by suboptimal adherence and adherence psychosocial and structural barriers. Forty percent of Latino men who have sex with men with HIV do not achieve viral suppression, largely due to suboptimal adherence. The proposed study seeks to evaluate the efficacy of stepped care strategies in improving antiretroviral therapy adherence among Latino men who have sex with men.